Specification And Patterning of Developing Blood Vessels

As described in the goals and objectives section of this report, this project consists of three specific aims: Developing Tools for Experimental Analysis of Vascular Development in the Zebrafish The development of new tools to facilitate vascular studies in the zebrafish has been an important ongoing aim of this project. Previously, we (i) established a microangiographic method for imaging patent blood vessels in the zebrafish and used this method to compile a comprehensive staged atlas of the vascular anatomy of the developing fish (http://eclipse.nichd.nih.gov/nichd/lmg/redirect.html), (ii) generated a variety of transgenic zebrafish lines expressing different fluorescent proteins within vascular or lymphatic endothelial cells, making it possible for us to visualize vessel formation in intact, living embryos, and (iii) developed methodologies for long-term multiphoton confocal timelapse imaging of vascular development in transgenic fish. Recent technical advances have greatly facilitated generation of new transgenic lines in the fish, and we are currently developing many new lines useful for in vivo vascular imaging as well as for in vivo endothelial-specific functional manipulation of signaling pathways involved in vascular specification, patterning, and morphogenesis. We are also developing new transgenic tools to facilitate high-throughput whole genome profiling of gene expression in selected cell types, i particular in vascular endothelium. Genetic Analysis of Vascular Development We use forward-genetic approaches to identify and characterize new zebrafish mutants that affect the formation of the developing vasculature. We are carrying out an ongoing large-scale genetic screen for ENU-induced mutants using transgenic zebrafish expressing green fluorescent protein (GPF) in blood vessels. We have screened well over 2000 genomes to date, and identified over 100 new vascular mutants with phenotypes including loss of most vessels or subsets of vessels, increased sprouting/branching, and vessel mispatterning. A bulked segregant mapping pipeline is in place to rapidly determine the rough position of newly identified mutants on the zebrafish genetic map, and fine mapping and molecular cloning is in progress for many mutants. We have previously positionally cloned the defective genes from a number of vascular-specific mutants, including violet beauregarde (defective in Alk1/acvrl1), plcg1 (defective in phospholipase C-gamma 1), kurzschluss (defective in a novel chaperonin), beamter (defective in trunk somite and vascular patterning), etsrp (an ETS-related transcription factor), and cds2 (defective in recycling a key intracellular substrate required for vascular signaling). We are currently focusing on several mutants mutants affecting VEGF-dependent and VEGF-independent vascular signaling pathways. Ongoing mutant screens and positional cloning projects in the lab are continuing to yield a rich harvest of novel vascular mutants and genes, bringing to light new pathways regulating the formation of the developing vertebrate vasculature. We have also recently developed a SNP map for the zebrafish and web-based tools that allow us to use whole-genome and whole-exome sequencing to uncover the defective genes in out mutated zebrafish. Analysis of Vascular Patterning and Morphogenesis We have used multiphoton time-lapse imaging to characterize patterns of vessel assembly throughout the developing zebrafish, and ongoing studies in the laboratory are aimed at understanding how this pattern arises and the what cues guide vascular network assembly during development. We previously demonstrated that known neuronal guidance factors play an important previously unknown role in vascular guidance and vascular patterning, showing that Semaphorin signaling it is an essential determinant of trunk vessel patterning. Current studies are aimed at further understanding the role of additional factors guiding the patterning of developing vascular networks in vivo, both in the trunk and in vascular beds in the eye, aortic arches, hindbrain, and other anatomical locales.